Intervention for Chronic Insufficient Sleep in Young Adult Cancer Patients and Survivors

PROJECT SUMMARY
Insomnia – defined as difficulty falling asleep, staying asleep, or nonrestorative sleep – is often
accompanied by symptoms that impair daily function such as fatigue, difficulty concentrating, and
mood disturbance. Affecting up to 75% of the estimated 650,000 young adult cancer survivors in
the United States, insomnia has a myriad of psychological and medical sequelae that compound
late in long-term effects of cancer diagnosis and treatment, including increased risk of mortality.
Cognitive behavioral therapy for insomnia (CBT-I) remains the gold standard for managing
chronic insomnia. Nevertheless, widespread access to trained CBT-I providers, even in
accredited sleep centers, remains elusive: trained CBT-I therapists remain limited in number and
traditional in-person CBT-I therapy can be time and cost prohibitive for patients. Newer attempts
to develop automated web-based CBT-I are more didactic than interactive and can involve
counterproductive use of smartphone screens at bedtime that can be activating and suppress the
melatonin needed for sleep. To address this critical gap in young adult cancer survivorship care,
we propose the More Sleep Hours Electronic Education Program (More SHEEP): a CBT-I solution
using a screen-free, conversational, AI-driven smart speaker, custom lighting to plan, remind and
support YACS about the changes required to overcome insomnia, and a smart router to report on
bedtime screen use. We propose a multi-phase project involving active patient stakeholder input
and an iterative design process that will achieve the following Specific Aims: Aim 1) maximize
feasibility, usability, and acceptability of the interactive CBT-I prototype; Aim 2) finalize the
prototype and conduct pilot field testing of the intervention for usability; Aim 3) conduct a
randomized controlled trial to determine the impact of these integrated CBT-I components on
insomnia symptoms among young adult cancer survivors compared to an attention control.
Successful completion of these Aims will further our long-term goal of providing novel, affordable,
available, scalable, evidence-driven solutions for moderate-severe chronic insomnia among
young adult cancer survivors. Furthermore, this technology can eventually be translated to other
patient populations living with cancer or other serious illnesses.

Public health relevance
PROJECT NARRATIVE Young adult cancer survivors (YACS) commonly experience chronic insomnia due to many factors such as cancer related symptoms, effects of anti-cancer therapies, co-morbid mood disorders, and/or other psychosocial and economic stressors. Cognitive behavioral therapy for insomnia (CBT-I) is the gold standard for insomnia management but remains challenging to deliver to patients due to limited numbers of trained therapists, inconvenient scheduling availability, or prohibitive therapy costs. To address this critical gap in young adult cancer survivorship, we propose to develop and test efficacy of the More Sleep Hours Electronic Education Program (More SHEEP), a novel system of smart speaker, smart lighting, and specialized Wi-Fi router that delivers AI-driven CBT-I to patients at home.